SMAC Mimetics as Broad-Spectrum Antivirals

ABSTRACT
Antivirals that are currently in clinical use target a limited number of viruses or viral subgroups, have moderate
efficacy and are prone to resistance. Current approaches for antiviral development mainly target viral proteins
with enzymatic activity. A disadvantage of this approach, especially for RNA viruses, is that their small genomes
offer few drug targets and high mutation rates lead to rapid emergence of drug-resistant strains. The discovery
of potent, broad-spectrum antivirals with a high barrier to resistance therefore remains an urgent, unmet medical
need for the treatment of endemic and emerging viral infections. Agents with these properties will most likely
target host factors that are required for replication of multiple viruses and/or innate immune circuits that govern
endogenous cellular defense mechanisms. SMAC mimetics, first developed to induce immunogenic death of
tumor cells, are now emerging as such pan-antivirals. These agents simulate the activity of endogenous SMAC
to block the action of inhibitor of apoptosis proteins (IAP). Although best known for their regulation of caspases
during inflammation and cell death, IAPs also influence ubiquitin (Ub)-dependent signaling pathways that
modulate innate immune responses. Several SMAC mimetics have already entered clinical trials for cancer
treatment. As for antiviral therapy, research thus far has focused on SMAC mimetics for treatment of chronic viral
infections, such as Hepatitis B virus and as latency reversal agents (LRAs) of HIV-1 infection. A recent report
described the antiviral activity of a potent, monovalent SMAC mimetic against flaviviruses, SARS-CoV-2 and
influenza A13. We have generated similar findings with SARS-CoV-2, Dengue 2 and influenza A using SMAC
mimetics developed by our group. Owing to our current HIV-1 LRA program, we have novel compounds in hand
that feature a range of activity profiles. We hypothesize that SMAC mimetics can be developed into potent pan-
antivirals because they preferentially kill infected cells, which are sensitized to death due to activation of innate
immune circuits. We recognize that SMAC mimetics may also affect cellular processes universally required for
or inhibiting viral replication. This project will focus on RNA viruses with pandemic potential, including influenza
A, flaviviruses (Dengue, Zika and West Nile), and SARS-CoV-2 variants. In Aim 1 we propose to investigate the
breadth and potency of the antiviral activity of SMAC mimetics. Here, we will also delineate the stage of the viral
replication cycle that is affected by SMAC mimetics and/or that triggers their antiviral properties. Aim 2 will rely
on systems biology approaches to identify the host factors that are implicated in SMAC mimetic antiviral activity.
Overall, the proposed studies will identify the mechanisms and pathways that are responsible for the antiviral
activity of SMAC mimetics and enable their further optimization as broad-acting antivirals.

Public health relevance
PROJECT NARRATIVE Antivirals that are currently in clinical use target a limited number of viruses, have moderate efficacy and are prone to resistance, therefore the discovery of potent, broad-spectrum antivirals with a high barrier to resistance remains an urgent, unmet medical need for the treatment of endemic and emerging viral infections. This project focuses on using SMAC mimetics as broad-spectrum antivirals for RNA viruses of pandemic potential. The proposed studies will contribute to identifying the mechanisms and pathways utilized by SMAC mimetics and enable their further optimization as broad-acting antivirals.